What Does Health Insurance Do? Evidence from the Oregon Health Insurance Lottery

OTHER PROJECT INFORMATION – Project Summary/Abstract
Understanding the consequences of health insurance coverage is central to evaluating proposals to expand or
modify health insurance coverage in the U.S. Yet there is remarkably little convincing evidence on the impact
of insuring the uninsured on their medical utilization, health outcomes, health behaviors, or overall well-being,
largely because enrolling in health insurance is a choice that is made jointly with other choices that determine
these outcomes. This project takes advantage of a remarkable opportunity to provide just such evidence. For a
limited window in early 2008, Oregon opened a waiting list for enrollment in its public health insurance program
for low income adults, and then randomly drew names from the list to determine who would be given the
opportunity to enroll. This unique policy environment provided researchers with a rare occasion to bring the
strengths of random assignment – the standard in medical trials – to address a critical social policy question.
This proposal builds on our prior work assessing the effects of Medicaid on health care use, health, and well-
being, including a focus on the near-elderly (those aged 50-64) whose health risks are in many ways similar to
those aged 65 and up and who will soon age onto Medicare themselves. We found that Medicaid substantially
increased health care use across settings (including primary care, hospitals, prescription drugs, and
Emergency Departments (EDs)); reduced financial strain (including bills sent to collection and catastrophic out-
of-pocket expenses); and reduced the prevalence of depression; but had no detectable effects on several
measures of physical health (including blood pressure, cholesterol, and diabetic blood sugar control). This
continuation project will leverage our work on the “Oregon Health Insurance Experiment” or OHIE to build
several new data sets and conduct new analyses to assess multifaceted effects of Medicaid coverage on
health and other outcomes, including: the evolution of hospital and ED use over time; the substitutability of
different sites of care; patterns of care for chronic physical conditions and mental health, including diabetes,
asthma, and depression; dental care; spillovers to population health care use and health outcomes. As policy-
makers and stakeholders assess the broad consequences of expanded access to health insurance, we believe
these analyses will add crucial evidence on the many potential effects of Medicaid on program use, health care
quality, and long-term health.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Understanding the consequences of health insurance coverage is central to evaluating proposals to expand or modify health insurance coverage in the U.S. The proposed research builds on a successful research program taking advantage of a unique policy experiment in Oregon to evaluate the causal effects of health insurance on health care and health outcomes.